Visual Science Training Program

Project Summary
In this renewal application, we request funding for the Visual Science Training Program (VSTP)
for an additional five years (2025-2030). The program is directed by Donald Zack and co-
directors Jeremy Nathans, Laura Ensign, and Amer Riazuddin. The goal of the program is to
recruit young, talented scientists into the visual sciences, and to provide them with broad
theoretical and methodological research training, which will allow them to contribute to our
understanding of the biology of vision and the pathological mechanisms responsible for visual
loss in the context of human disease.
The VSTP is a combined effort of the Department of Ophthalmology (Wilmer Eye Institute), the
Department of Neuroscience, the Department of Molecular Biology and Genetics, and the
Department of Genetic Medicine of the Johns Hopkins University School of Medicine, and the
Department of Biology of the Johns Hopkins University Krieger School of Arts and Sciences.
The diverse faculty from multiple departments across two schools of Johns Hopkins provides a
multidisciplinary training platform covering many of the major avenues of modern visual science.
Johns Hopkins is fortunate to have a large number of investigators exploring different avenues
of vision research; their approaches range from the molecular and cellular to the system levels,
and the technologies they employ include cell biology, molecular biology, biochemistry,
developmental neurobiology, stem cell biology, electrophysiology, functional imaging,
psychophysics, bioinformatics, genomics, and genetics. Naturally, this diverse vision research
community provides a wide variety of research options for VSTP trainees.
In this VSTP renewal application, we are proposing to accept two predoctoral students per year
and support both of them for two years, and to accept one postdoctoral fellow per year, and to
support this fellow for one year. As part of our training program, the VSTP, in collaboration with
Wilmer Eye Institute and other Hopkins graduate programs, organizes and provides vision-
related courses, seminars, and related activities. Additional training in the problems of clinical
ophthalmology, with an emphasis on translational problem solving, is available to all VSTP
trainees through the ophthalmology rotations and grand rounds. To suffice, through these
programs, we hope to continue and expand upon the success of VSTP in recruiting, inspiring,
and training the next generation of vision scientists.

Public health relevance
Project Narrative The overall goal of the Visual Science Training Program (VSTP) is to recruit talented young researchers both pre- and postdoctoral fellows and provide them a broad research training with an overall emphasis on vision loss in the context of human disease, which will enable them to discover new horizons and contribute to our understanding of the biology of the visual cascade and the underlying pathologies resulting in loss of vision.